AI-linked cytomics-on-a-chip to enable near-real time identification and management of oral lichenoid lesions in primary care

Abstract
Oral cancer, which affects 54,000 Americans per year, has one of the worst outcomes and highest expense
rates of all cancers, in large part due to late-stage diagnosis. Late-stage oral cancer has a 5-year survival rate
of only 18%. Early detection leads to an improved 5-year survival rate (85%), less aggressive treatment
regimens, and lower treatment cost burdens. Yet, only 28% of oral and oropharyngeal cancers are diagnosed at
an early stage, mostly due to the lack of opportunistic screening. At any point in time, over 10% of the US
population has an oral lesion, some of which will lead to cancer. For example, oral lichenoid conditions (OLC)
have a 1.4-2.85% 5-year malignant transformation rate. But general practitioner dentists, periodontists
otolaryngologists and oral and maxillofacial surgeons find it difficult to discriminate lesion risk based on visual
and macroscopic appearance because benign, pre-cancerous, and malignant lesions often present with similar
symptoms. While there is significant activity in the development of AI-linked diagnostic models for risk profiling
oral lesions, the vast majority of these are not suitable for point-of-care (POC) use. There is a critical need for
more accessible and accurate screening tools. To address this major gap in care, OraLiva proposes to
develop a tool for AI-linked cytomics-on-a-chip to enable practitioners to identify and effectively manage
OLC in primary care. In Phase I equivalent work, OraLiva validated C-AIIDE (Cytology Artificial Intelligence
IDEntification), the first portable, programmable single cell cytology platform for POC use, for the ability to
distinguish clinically significant oral lesions, including oral epithelial dysplasia and oral squamous cell carcinoma.
A 4-site NIH-sponsored international prospective clinical study recorded over 200 cellular features related to
biomarker expression, nuclear parameters, and cellular morphology per cell, encompassing ~2000 cells per
patient, representing nearly 13 million indexed cells. This cytology platform has revealed 128 new features for
better cellular discrimination, relative to established cytology predictors, among the diagnostic categories
studied. For this Direct-to-Phase II project, OraLiva will advance a tool for front-line dentists/clinicians to assess
lesions in primary care settings by undertaking five specific aims: 1) Design and produce alpha instrumentation
units that combine all the major features and functionality integrated into stand-alone analyzers that are suitable
for both research measurements and commercial launch of the initial oral lesion laboratory developed test (LDT);
2) Define optimal cytosignatures to differentiate between OLC+ and OLC- lesions; 3) Compile cytopathology
database for OLC+ and OLC- lesions and develop new AI linked diagnostic models using the new cytosignatures
and the new instrumentation; 4) Develop a clinically actionable intuitive OLC status report that can be accessed
via cloud-based infrastructure; and 5) Define optimal beta product requirements for the future widely distributed
regulated point of care platform. This program has potential to have major impact by identifying lesions that may
be monitored in primary care when interventions are more impactful, less expensive, and less invasive.

Public health relevance
Narrative Oral cancer has one of the worst outcomes and highest expense rates of all cancers, in large part due to late- stage diagnosis. Early diagnosis is complicated by a lack of accessible and accurate screening tools allowing general practitioner dentists and peridontists to discriminate between oral lesions based on cancer risk. This project will help develop a tool for AI-linked cytomics-on-a-chip to enable the identification, assessment, and management of oral lichenoid conditions (OLC) in primary care, ensuring malignancies are identified earlier when interventions are more impactful, less expensive, less invasive, and more likely to improve patient outcomes.